Smartphone Machine Learning Speech Enhancement System for Hearing Aid Devices for the Underserved and Rural Populations

Abstract
This proposal responds directly to the purpose of the RFA-MD-23-003 SBIR Funding Opportunity Announcement
(FOA). Nearly 44 million Americans experience hearing loss, but as much as 86% of adults who could benefit
from hearing aid devices (HAD) do not use them. Untreated hearing loss is almost twice as prevalent in rural
areas. More than 46 million people live in rural America, but these communities face significant barriers and
delays in accessing care and experience a lack of providers for audiology services. The average retail price of
HADs was $4,700, making it prohibitively expensive for the rural and minority populations who have lower
incomes. Hearing loss is also highly prevalent in black and Latino/Hispanic communities and growing, but older
black adults were 58% and Mexican American older adults were 78% less likely to use HADs, due to reasons of
high cost and lack of insurance coverage. Aside from cost, concerns about comfort, effectiveness and
satisfaction are the other significant barriers to HAD usage. The FDA made over-the-counter (OTC) HADs a
reality in 2022, creating a new hearing option for many adults with perceived mild to moderate hearing loss. The
introduction of OTC HADs is set to increase accessibility and affordability of hearing care for underserved
populations.
A common complaint of HAD users is the HAD inability to reduce ambient background noise completely, instead,
the background noise is amplified along with the human voice. Speech enhancement algorithms continue to be
developed and the most advanced found on high-end costly HAD platforms. This project will develop machine
learning (ML) based smartphone software with a Graphical User Interface (GUI), to bring these advanced speech
enhancement and noise reduction algorithms to the OTC HAD users. With smartphone assistive software and
the predictive power of ML, our proposed solution to reduce background noise and enhance speech, will
significantly improve OTC HAD accessibility, affordability, and acceptance, thus benefitting the rural and minority
populations the most.

Public health relevance
Project Narrative Nearly 44 million Americans experience some hearing loss, but as much as 86% of adults who could benefit from hearing aid devices (HAD) choose not to use them. HAD usage is disproportionately lower among rural and minority populations. Concerns about access, cost, comfort, effectiveness, and satisfaction are key barriers to HAD usage.